The EcoCyc Model Organism Database for Escherichia coli

Project Summary
SRI International and a group of collaborators propose to further develop the Escherichia coli EcoCyc
database (DB). EcoCyc is and will continue to be freely and openly available, and is accessible to scien-
tists through the Internet, as downloadable data ﬁles, and as a downloadable software application.
Scientists from multiple disciplines make wide use of EcoCyc; it has been cited 3,428 times, and
from 2015–2017, an average of 99,800 users per year visited the EcoCyc website. It serves as a gen-
eral reference source on E. coli for experimental biologists, and is particularly useful for the analysis of
functional-genomics experiments. The DB serves computational biologists who are undertaking global
studies of E. coli; metabolic engineers who are developing new methods for chemicals production, in-
cluding biofuels; and researchers and bioinformaticists who are using EcoCyc as the gold-standard
dataset to develop new computational methods, including the prediction of operons, promoters, and
protein functional linkages. Educators also use the DB.
We will update EcoCyc in an ongoing fashion to reﬂect new information about the genes, metabolic
pathways, and regulatory interactions of these important model organisms. Information will be inte-
grated from the biomedical literature and from large-scale experiments, such as data on gene essential-
ity, on nutrients supporting growth, and on protein interactions. We will continue a comprehensive and
ongoing effort to reﬁne steady-state metabolic network models of these organisms by validating model
predictions against many conditions of growth and non-growth for wildtype and knock-out strains.
The resulting models will have applications in anti-microbial drug discovery and metabolic engineer-
ing, and the model development process will lead to many improvements in the EcoCyc DB.
We will launch a new effort to curate the genes and proteins of E. coli strains other than the strain
served by EcoCyc. Thousands of E. coli strains have been sequenced; yet in many cases, their genome
annotations are of low quality. We will project curated gene annotations from EcoCyc and from other
E. coli strains to orthologs of those genes in the BioCyc DBs for hundreds of other E. coli strains, thus
signiﬁcantly improving the annotation quality of other E. coli strains, in a cost-effective fashion.
The project will also expand the Pathway Tools software used to query and analyze EcoCyc, such
as adding a tool for projecting newly curated gene and protein annotations to orthologs in other E. coli
strains.

Public health relevance
Project Narrative Escherichia coli is the most thoroughly studied bacterium on earth; therefore, a computer knowledge base that integrates experimental ﬁndings for this organism from thousands of scientiﬁc publications is a valuable and cost-effective resource for science and education. The comprehensive knowledge and computational tools available through EcoCyc accelerate the research of scientists who use this organism to develop biofuels, of scientists who study related pathogenic bacteria, and of scientists who work with the bacteria comprising the human microbiome.